Core B. Program Development (Pilot) Core

OTHER PROJECT INFORMATION – Project Summary/Abstract
Core B – Program Development (Pilot) Core
The program development core supports small-scale exploratory research on new and innovative project ideas,
thereby enriching the Center’s research agenda in its major thematic areas of study. These exploratory efforts
enable researchers to test the feasibility of larger projects on new topics, and to obtain the preliminary results
necessary to mount larger projects. The core also serves an important role in attracting outstanding senior
investigators to become involved in research projects in health and aging, and in assisting outstanding new
investigators in embarking on a research agenda in this area. Pilot projects are selected to advance one or more
of the following objectives: to further develop, fill gaps, or add dimensions to the major themes of Center
research; to explore topics that are more innovative or experimental; to test methods and obtain the preliminary
results necessary to mount larger projects; to engage highly accomplished senior scholars or highly promising
junior scholars in the collaborative research activity of the Center; to respond quickly to research opportunities
that arise based on policy developments or current events; to explore new data resources, new research
methodologies, experimental interventions, or cross-disciplinary approaches that enrich the Center’s impact; or
to involve researchers from other disciplines, or individuals with practical expertise, who can provide new
perspectives on Center research.